Concordance between Ecological Momentary Assessment (EMA) and Video-recorded Direct Observational Measures of Family Meal Healthfulness (Admin Supplement Gap Year Khadija Mohamed)

Abstract
The low to moderate success with childhood obesity interventions to date and the persistent obesity disparities
across race/ethnicity and socioeconomic status indicate the need to approach childhood obesity in a new and
innovative way. Building on the last three decades of research on childhood obesity, the main objective of the
proposed study is to utilize state-of-the-art intervention methods including ecological momentary intervention
(EMI), video feedback, and home visiting methods in partnership with primary care clinics and Community
Health Workers (CHWs) to examine whether increasing the quality of family meals (i.e., dietary quality,
interpersonal atmosphere) and quantity of family meals (i.e., frequency of meals) reduces childhood obesity.
Numerous studies have shown significant associations between family meal frequency and child weight and
weight-related behaviors (e.g., better diet quality, lower weight status). Research has also shown that the
quality of family meals, including dietary quality of the food served at family meals and the interpersonal
atmosphere during family meals, is associated with decreased childhood obesity risk. In addition, prior
intervention research has shown that immediate feedback on health behaviors (e.g., EMI, video feedback)
increases the likelihood of behavior change. Thus, the proposed individual randomized controlled efficacy trial,
based on our pilot study, tests combinations of the above factors (i.e., EMI, home visiting, video feedback)
across three study arms: (1) EMI; (2) EMI+Home Visiting (HV) with a Community Health Worker (CHW)+Video
Feedback; and (3) EMI+HV with CHW+Video Feedback+Virtual. All arms will receive 16 weeks of EMI family
meal tip messages delivered via smartphones. Arms 2 and 3 will additionally receive home visiting (eight in-
home visits; eight “Try it Yourself” activities) focused on family meal quality and quantity and a family meal prep
activity delivered by a CHW simultaneously with 16 weeks of EMI, as well as video feedback on family meal
behavior. Arm 3 will additionally be delivered virtually. All arms will receive an 8-week maintenance phase
allowing for progressively less support of families so they can increase self-efficacy and sustainability of
behavior change. The intervention will be carried out for 6 months with children at risk for overweight/obesity
(i.e., BMI ≥75%ile) who are ages 5-10 years (n=510), from low income and diverse households (i.e., African
American, Hispanic, Native American, White). Eligible children will be recruited through primary care clinics.
Drawing on Family Systems Theory, the intervention aims to change individual and family-level behaviors.
Specifically, the intervention will be delivered to the family unit and primary outcomes include child weight (i.e.,
BMI %ile) and diet quality (i.e., Healthy Eating Index). Secondary outcomes include parent and other family
member’s weight and weight-related behaviors. This study will change clinical practice by creating a new
model for childhood obesity treatment in primary care using CHWs as interventionists and mobile health
technology to intervene in real-time on parental stress and the home food environment to reduce obesity.

Public health relevance
Project Narrative This three-arm individual randomized controlled efficacy trial aims to reduce childhood obesity disparities in children ages 5-10 (n=510) from diverse households by increasing family meal quality (i.e., diet quality, interpersonal atmosphere) and quantity (i.e., family meal frequency). Innovative methodology (e.g., ecological momentary assessment (EMI), video feedback) will be used in partnership with primary care clinics and Community Health Workers (CHW) to test three arms: (1) EMI; (2) EMI+Home Visiting (HV) with CHW+Video Feedback; and (3) EMI+HV with CHW+Video Feedback+Virtual. Findings will result in a new model for childhood obesity treatment in primary care.